Protective role of Neuregulin-1 against cerebral malaria-induced neuronal injury and behavioral sequelae

Human cerebral malaria (HCM) is a severe form of Plasmodium falciparum (P.f.) malaria associated with
~500,000 deaths in children annually and impaired brain function in some survivors. HCM is characterized by
sequestration of parasitized red blood cells (pRBCs) in cerebral micro-circulation and induction of inflammatory
mediators, brain swelling and impaired consciousness with unarousable coma. We have determined that
circulating free heme and parasite histidine rich protein 2 (HRP2), by-products of pRBC lysis, are major causes
of brain inflammation, blood-brain barrier (BBB) dysfunction, and brain injury associated with HCM. However,
defining the mechanism(s) mediating these effects in HCM is challenging in the absence of suitable models. In
vitro 2D cell culture, 3D brain organoid and animal models (ECM; Plasmodium berghei ANKA in C57BL/6) all
indicate that heme and HRP2 induced cellular apoptosis, inflammation, and tissue disorganization. In ECM,
heme causes brain vascular endothelial cell apoptosis, alters Angiopoietins 1 and 2 ratios, upregulates CXCL10,
Heme Oxygenase 1, and tau as well as compromise BBB integrity through STAT3 signaling via matrix
metalloproteinase three (MMP3). Following a screen for therapeutic agents against ECM, we identified
Neuregulin- 1(NRG1), an 8 kDa neuropeptide currently undergoing clinical trials against heart failure, that
attenuates ECM when delivered intravenously at 5µg/kg. NRG1 mediates phosphorylation of ErbB4 (receptor),
activates AKT and inactivates STAT3 in human brain microvascular endothelial cells. ECM resistant mice
(BALB/c) constitutively expressed higher levels of NRG1 in brain tissue than ECM susceptible (C57BL/6) mice.
Since circulating NRG1 is severely depleted in both fatal HCM and ECM, levels of NRG1 need to be assessed
prospectively to ascertain amounts needed for augmentation to mitigate HCM severity. Interestingly, CD8+Tcell
PD1/PD-L1 signaling mediated ECM recovery and PD1 was upregulated by NRG1. Using a human stem cell-
derived neurovascular unit (NVU; brain chip), ECM and human subjects, we will determine the mechanism by
which NRG1 attenuates cerebral malaria. We hypothesize that therapeutic administration of NRG1 will attenuate
heme and HRP2-induced NVU damage and ECM mortality via NRG1/ErbB4 and PD/PD-L1 signaling. Our
objective is to functionally assess the key regulatory pathways mediated by NRG1 to attenuate ECM, and heme-
and HRP2-induced NVU damage. The specific aims are: 1) to test the hypothesis that an algorithm, consisting
of NRG1, heme, HRP2, and markers of neuronal injury and inflammation can predict HCM severity, mortality
and neurobehavioral sequelae; 2) to test the hypothesis that NRG1/ErbB4 and PD1/PD-L1 signaling crosstalk
protects against heme and HRP2-induced damage in human NVU; and 3) to test the hypothesis that NRG1
attenuates ECM brain injury and behavioral deficit via NRG1/ErbB4 and PD1/PD-L1 signaling. Understanding
the role of NRG1 in cerebral malaria pathogenesis and sequelae in survivors will enable us to determine the
feasibility of targeting NRG1 in clinical trials with the ultimate goal of improving the survival of children with HCM.

Public health relevance
Most adjunctive treatments developed to date against cerebral malaria have not reduced fatal outcomes mainly because treatments have focused on clearance of circulating parasites but neglected the involvement of damaging parasite and host factors appearing early in infection or remaining after treatment. The proposed study uses 3D in vitro models, animal, and human studies to clarify our understanding of the role of NRG1/ErbB4 and PD1/PD-L1 signaling in HCM severity in order to target NRG1 in clinical trials with the ultimate goal of improving survival rates in children with cerebral malaria. The proposed study will clarify the role of NRG-1 in attenuation of ECM and human cerebral malaria (HCM) and mechanisms mediating its function.